Target Antigen Identification to Generate a Cross-serovar Salmonella Vaccine

Project Summary
Systemic Salmonella infections are caused by distinct serovar groups that are typically defined as typhoidal,
paratyphoid, or non-typhoidal. While there are new conjugate vaccines for typhoid, there are still no licensed
vaccines for systemic Salmonellosis caused by paratyphoid or non-typhoidal serovars, despite the fact that
these infections account for more than 50% of all deaths. Much of what we know about Salmonella protective
immunity comes from researchers who study non-typhoidal strains in a mouse model since typhoid and
paratyphoid strains do not infect any experimental animals. In this renewal application we describe the
generation of a new mouse model that will allow side-by-side analysis of typhoidal and non-typhoidal disease.
This is an important first step in understanding protective immunity to these different infections as a foundation
for cross-serovar vaccine development. We will use this mouse model to, (i) compare host immunity and
vaccine approaches to typhoidal and non-typhoidal Salmonella side-by-side in an animal model for the first
time, (ii) identify new protective antigen targets of liver Tissue Resident Memory (TRM) CD4 T cells that protect
against typhoidal, non-typhoidal, and Paratyphi infections. Together, these studies will provide the foundation
for the development of a cross-serovar vaccine for all major causes of systemic Salmonellosis.

Public health relevance
Project Narrative Comparing protective immunity to Salmonellosis caused by Typhoidal, Paratyphi, and non-typhoidal strains is not currently possible since Typhi or Paratyphi strains do not infect mice or any other animals. In this renewal application, we will explore a new animal model of typhoid to continue our sub-unit vaccine strategy focussed on antigens targeted by liver resident CD4 T memory cells. The goal of the application is to identify novel vaccine targets of liver resident CD4 T cells to develop a cross-serovar vaccine that could protect against the major causes of systemic Salmonellosis.